Proteomic signatures to predict drug response in cancer

Abstract
Precision medicine in oncology requires accurate prediction of drug response to guide personalized
treatment decisions. We developed a pharmacoproteomics platform that links kinome activity in liver cancer
cell lines to kinase inhibitor drug response. Preliminary results indicate that our KI-Predictor’s ability to identify
dysregulated kinase signaling is highly dependent on cellular context. To examine and optimize our predictive
model, we will use samples of normal human liver tissue and other inputs and evaluate its performance using
additional liver cell lines and the Genomics of Drug Sensitivity in Cancer (GDSC) datasets. In parallel, we
propose to evaluate our KI-Predictor by profiling kinome activity in clinical liver cancer samples, selecting
candidate kinase inhibitors for testing in organotypic slice cultures derived from each individual patient’s tumor.
By comparing the predicted drug response with the observed response in the organotypic slice culture models,
the accuracy and reliability of the KI-Predictor model can be evaluated. This validation step enables the
assessment of the model's ability to capture the complexities of the tumor microenvironment, including
interactions between cancer cells, stromal cells, and the extracellular matrix.

Public health relevance
Public Health Relevance/Narrative Precision medicine in oncology requires accurate prediction of drug response to guide personalized treatment decisions. We developed a pharmacoproteomics platform that links kinome activity in liver cancer cell lines to kinase inhibitor drug response; we will optimize our KI-Predictor in liver cancer and test its ability to select useful kinase inhibitor drugs in cell lines and organotypic slice culture models as a validation platform for predicting drug response in cancer. The combination of prediction and drug testing in a validation platform enhances the accuracy and translatability of the predictions, facilitating the advancement of precision medicine in oncology by aiding clinicians in selecting optimal treatment strategies tailored to individual patients.